Patient Navigator plus Remote mHealth Adherence Support with Incentives: Understanding Criminal Justice Effects

PROJECT SUMMARY/ABSTRACT
Polysubstance use and mass incarceration are twin epidemics. The rise in combined
methamphetamine and opioid use along with the simultaneous creeping of mechanisms to address
substance use disorder into the many arms of the criminal legal system from prisons/jails,
probation/parole, policing, and court-mandated treatment or diversion programs have imbedded the
legal system in the lives of people who use drugs. Combined use is already associated with more
medical and psychosocial comorbidities, more stigma, less frequent treatment, and more legal
system involvement. Despite mechanisms within the criminal legal system to address substance use,
it is often combined with exclusion, punishment, violence, poor health outcomes, and isolation from
services. Thus, involvement in the criminal legal system is likely to impact treatment for substance
use disorder in complex ways that have not yet been studied. This administrative supplement in
response to PA-20-272 proposes to investigate the role of the criminal legal system in the parent R34
grant “Patient Navigator plus Remote mHealth Adherence Support with Incentives to Improve Linkage
and Retention among Hospitalized Patients with Opioid and Methamphetamine Use Who Initiate
Buprenorphine.” We will conduct qualitative interviews among approximately 20 participants in the
parent study, exploring encounters with various arms of the legal system and the effects it has had on
their substance use and treatment, focusing specifically on the unique experiences of people who use
methamphetamine and opioids. We will then apply the insights from these interviews to improve
resources and training for the patient navigator arm of the parent trial so that they can help patients
avoid adverse effects of criminal legal system involvement. This study will address gaps in knowledge
about the effects of legal system involvement—which is already common in people who use drugs
and may be an even greater challenge for people who also use methamphetamine—on linkage to
and retention in treatment, helping to better understand the social-structural determinants and
develop better treatment and intervention strategies. To that end, it will also apply the knowledge
generated from interviews to enhance the parent study objectives of increasing linkage and retention
in treatment and improve secondary outcomes of reduced substance use and emergency room visits.

Public health relevance
PROJECT NARRATIVE Combined use of methamphetamine and opioids is increasingly prevalent and poses new challenges to developing multidisciplinary substance use treatment strategies, especially given the unique behavioral consequences of this drug combination. Our knowledge of how criminal legal system involvement associated with combined methamphetamine and opioid use affects treatment for polysubstance use disorder is emerging, and there is a need for research using detailed qualitative methods to elucidate these effects on the lives of people who use drugs through exploring their individual experiences. We therefore propose to conduct semi-structured interviews among approximately 20 participants in the parent study “Patient Navigator plus Remote mHealth Adherence Support with Incentives to Improve Linkage and Retention among Hospitalized Patients with Opioid and Methamphetamine Use Who Initiate Buprenorphine” exploring the impact of criminal legal system involvement on treatment for substance use disorder and to use this information to develop needs- based resources and training to improve the patient navigator arm of the study.